Administrative Core

OTHER PROJECT INFORMATION – Summary/Abstract
Administrative Core
The Center mechanism for supporting scientific research offers important benefits beyond those available from
a set of independent studies. The realization of these benefits, however, requires deliberate attention to
coordination, collaboration, and integration in all aspects of the research process. The Administrative Core
supports all domains of Center leadership, administrative support, trial metrics, and networking. The leadership
role includes all aspects of programmatic and intellectual leadership. A key feature of this role is the integration
of recommendations from the Center’s external advisory committee and review panels. The administrative
support role involves clinical trial monitoring and all Center operational management. Key tasks include budget
and personnel management, trial results reporting and dissemination, data and safety coordination, travel
coordination, and meeting organization. The trial metrics role involves the development and utilization of metrics
to evaluate clinical trial success. Metrics will be used to track trials’ output (e.g., publications, data resources),
progression through the NIH Stage Model and representation across stages; gauge the diversity of our
investigator community; and measure the number and type of collaborations. A key function is the ex-post
examination of each trial’s ex-post statistical power and lessons learned for future work. Finally, the networking
role will involve communications with Center and NBER affiliates, outreach to prospective trial investigators, and
dissemination of trial results.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Administrative Core Health is a foundational source of wellbeing for people of all ages. The Administrative Core will provide the infrastructure and critical operational support that allows the NBER Roybal Center to develop and test interventions that address real-world problems in ways that directly and cost-effectively improve population health.